Translational Research Support Core

TRANSLATIONAL RESEARCH SUPPORT CORE - ABSTRACT
The Translational Research Support Core (TRSC) plays a key role in the research pursued in CEED by
supporting the design and implementation of innovative “research that matters” for communities in NJ and
beyond. TRSC offers expertise on planning and conducting research across the NIEHS translational research
framework. Informed by basic laboratory research within CEED and concerns of community members, TRSC
facilitates research through the design and execution of 1) population/observational epidemiology, 2) clinical
trials and intervention studies, and 3) implementation of meaningful results. This is accomplished through
bidirectional partnerships between TRSC leadership and CEED researchers and trainees, as well as close
communication with the Community Engagement Core (CEC). After consultation with researchers to identify
clear study objectives, TRSC offers an array of services including design of human/population studies; screening,
recruitment, and retention of subjects for panel studies, trials, and cohorts; management of protocols and data
to ensure regulatory compliance; collection of biospecimens; and data analysis, interpretation, and dissemination
of study findings. TRSC also provides field support for study management, survey research, and environmental
and biospecimen collection, as well as sample storage within a state-of-the art sample management system.
TRSC leverages the infrastructure available at the NJ Alliance for Clinical and Translational Science (NJ ACTS),
the first and only Clinical and Translational Science Award (CTSA) in NJ. Through this partnership, TRSC has
been able to expand the reach of its services by greater access to populations and cohorts, as well as informatics
tools that enable broader recruitment of study participants. During the next grant cycle, CEED’s efforts will be
focused on addressing environmental health-related disease by placing affected communities at the center of
our research. Close relationships with local communities will enhance TRSC’s capacity to accelerate translation
of research findings to people who live/work in settings that put them at increased risk of exposure to hazards
using evidence-based implementation science approaches. TRSC will ensure rigorous and comprehensive
support for research involving human participants and community partners. In collaboration with the
Administrative Core and Career Development Program, TRSC will connect early career scientists and trainees
with opportunities to attain skills in translational science including workshops, asynchronous online learning, and
through individual mentorship by TRSC leadership. These activities support the ability of CEED to reduce health
risks within NJ and improve public health across the state and region.